“PVAHCS Nutrition-Focused Summer Research Practicum”

Project Summary/Abstract
Registered Dietitians (RDs) as a profession are not representative of the communities they serve. This is due in
part to obstacles for minority groups to join the profession. Nutrition research is also lagging behind other
medical research in terms of funding, quality, and scope. Part of the reason for this is a lack of nutrition
professionals who are research prepared. Exceptionally few research learning programs exist with a nutrition
focus.
The Phoenix VA Nutrition-focused Summer Research Practicum (PVAHCS SRP) aims to help remedy these
gaps by recruiting students from under-represented communities in science and providing training and career
preparation in nutrition research. We have developed a rigorous and flexible program for PVAHCS SRP
Scholars with the aims of improving Scholar confidence and self-identification as a researcher, increasing the
diversity of the VA workforce, and cultivating interest and participation in nutrition research. The PVAHCS
SRP prepares Scholars for success and helps to overcome barriers that often preclude success for some
students from marginalized communities. We accomplish this by (a) a progressive design that encourages
Scholars to return for up to 3 years to the program and build on their previous work and learning, (b)
individualized goals and learning to meet unique Scholar needs and interests, (c) alternative learning models
that primarily teach through doing, “failing up” and peer-to-peer instruction, and (d) comprehensive
mentoring plans intended to lay the ground-work for life-long mentorship for Scholars. Because we understand
the barriers that students from nontraditional backgrounds may face, we offer flexibility for virtual and
telework as much as possible while still accomplishing the program goals. We pay Scholars competitively and
provide professional develop and career counseling through our comprehensive mentorship program, thereby
setting them up for success in their chosen field.
The PVAHCS SRP accepted 4 Scholars into the Practicum the first year, and six the following year, with a total
of eight Scholars in total. Results to date show subjective and objective improvements in confidence by 1.9
points on average each summer. To date, 38% of Scholars who have completed 1 year of the Practicum, have
applied to, and been accepted into a subsequent year of the Practicum. Another 38% percent were accepted
into VHA training program. Scholars belonging to one or more under-represented group in science have
ranged from 67-100% each year. Our Scholars presented four poster presentations at The Annual Biomedical
Research Conference for Minoritized Scientists (ABRCMS) in 2023.
Lessons learned from the first two years of the Practicum have better prepared the program for success. These
include more stream-lined administrative processes for onboarding and starting onboarding early with
collaboration and support from central office and other sites. Our curriculum is under continuous process
improvement based on feedback from faculty and Scholars. The Practicum was a heavier administrative load
than we had originally anticipated. Because of this, we are hiring a coordinator that will support this program
and our other nutrition research programs.
Overall, the Practicum has had tremendous buy-in and support from PVAHCS leadership, research staff,
nutrition staff, and Scholars. Scholars have met and exceeded expectations and grown myriad ways. As stated
by one Scholar: “Before I wanted to be able to understand research to be able to read and understand literature.
Now I want to participate in research. I didn’t know anything about the VA. Now I have a good perception of
the VA.”

Public health relevance
The vision of the PVAHCS Nutrition-Focused Summer Research Practicum is to provide superior whole health and nutritional sciences research training to drive positive change for Veterans, by putting innovation, diversity and daring leadership at the forefront. It focuses primarily on the nutritional sciences and other areas of VA research. This program combines many novel features. Scholars accepted into the Practicum are encouraged to return to the program for up to three years, which progressively build on previous experiences. The Practicum is rigorous, yet individualized and flexible. Didactics include tours, elective activities, Journal Clubs and bi- weekly half day seminars. Seminar topics include Literature Review, Research Development, DEI, Professional Development and Soft Skills, Research Dissemination, Networking, Data Bootcamp, Meet the Investigator, American Veteran, and Research Ethics. Scholars receive comprehensive mentorship, customizable research experiences, and professional development training that are not typical of their traditional fields of study.